Director Genomics Shared Resource

PROJECT SUMMARY / ABSTRACT
The current application seeks salary support for Prashant K. Singh, PhD who serves as the Director of the
Genomics Shared Resource (GSR) at Roswell Park Comprehensive Cancer Center (Roswell Park) and
Assistant Professor in the Department of Cancer Genetics and Genomics. Dr. Singh works closely with Cancer
Center Support Grant (CCSG) leadership and members to provide a centralized, efficient approach of supporting
research, clinical and population based genomic endeavors, while facilitating peer-reviewed funding,
publications, and recruitment efforts. Dr. Singh supports all genomics initiatives at Roswell Park by providing
expertise in all aspects of assay design, sample preparation, QC, data generation, and analyses. Dr. Singh acts
as a subject matter expert for CCSG members utilizing genomics approached to acquire and analyze genomic
data sets across basic, translational, clinical and population studies. Dr. Singh plays a vital role in discovery-
driven research of CCSG members as well as in diagnostic applications that complement traditional clinical
evaluation of cancer samples. Dr. Singh is involved in the research and design of NGS assays that support the
goals of developing personalized therapies based on the unique genetic makeup of a patient’s cancer. The GSR
is an integral part of Roswell Park’s CCSG (P30CA016056) for which the cancer center Director, Dr. Candace
Johnson, serves as the Principal Investigator. In the current CCSG reporting period (2018-present), as of
October 2023, 128 NIH/NCI grant applications utilizing the GSR services and Dr. Singh’s expertise were awarded
to Roswell Park faculty. In the same period, the GSR contributed to 210 peer reviewed publications. Dr. Singh
has over 19 years of experience in the field of genomics and epigenomics with a strong focus in cancer research.
Dr. Singh actively participates in meetings focused on correlative sciences related to clinical trials, multi-PI, and
multi-institutional programs such as the Roswell Park Ovarian SPORE (P50CA159981-08), P01 Program grant
(P01CA234212), and the Western New York Center for Research on Flavored Tobacco Products (CRoFT,
U54CA228110). Dr. Singh’s leadership and expertise is critical for continued success of the CCSG program and
Roswell Park’s research mission. As the PI of Roswell Park’s CCSG (P30CA016056), Dr. Johnson will serve
as the Unit Director for this R50 Core-based scientist (PAR-22-188) application.

Public health relevance
PROJECT NARRATIVE The long-standing history and contribution to the Human Genome Program through clone generation (RP11 BAC libraries), high throughput mapping, array technology development, and distribution of these resources worldwide, provides a track record documenting expertise of the Genomics Shared Resource (GSR), which is an integral part of the Roswell Park Comprehensive Cancer Center (Roswell Park) Cancer Center Support Grant (CCSG) program (P30CA016056, PI Dr. Candace Johnson). As the Director of the GSR with over 19 years of relevant experience, Dr. Prashant Singh’s efforts are dedicated to support the mission of the GSR, which is to provide state-of-the-art instrumentation and expertise that enables CCSG members to acquire and analyze genomic data sets across basic, translational, clinical and population studies. Dr. Singh’s intellectual and practical contributions are invaluable to NCI-funded projects of the CCSG program members. Funding Dr. Singh as an NCI Core-based Scientist will ensure the stability and continued growth of a vital resource to Roswell Park’s CCSG programs and allow him to dedicate his time for novel technology development.